Animal Medicine Infrastructure Support

The Translational Research Program (TRP) serves three major functions at the VRC: 1) provides centralized support and service for all in vivo research conducted at the VRC, 2) conducts collaborative research and animal model development, and 3) operates a fully accredited lab animal facility. TRP provides all aspects of oversight and programmatic assistance to support teaching, training, and in vivo research by managing all preclinical safety and regulatory issues, ensuring judicious and humane use of animals in compliance with all institutional, local, state, and federal guidelines. It is the VRC primary resource for consultation, collaboration, and professional assistance in selecting appropriate animal models or establishing novel models to study disease and vaccine effects. TRP pursues independent and collaborative research projects related to animal model and preclinical product development for influenza, emerging infectious diseases such as alphaviruses, and other biodefense-focused diseases. Translational research is conducted to advance vaccine products from preclinical stages toward human clinical trials by actively monitoring and overseeing efficacy, safety, and toxicology studies in preparation for regulatory oversight of product development. TRP also investigates novel vaccine delivery methods to enhance efficiency, vaccine efficacy, and safety. TRP serves as a fully accredited AAALAC in-house animal facility, adhering to all federal regulations. The facility provides quality animal husbandry services, veterinary care, and facility management support for rodents. The facility offers preventive medical care, routine surveillance, and quality assurance for vendor- and colony-produced animals and may also establish and maintain its own mouse breeding colonies if necessary. A variety of technical services are performed by facility staff, including parenteral injections or oral administration of Animal Care and Use Committee (ACUC)-approved experimental materials; blood, tissue, and serum collection; surgical manipulations; animal identification procedures; electroporation procedures; anesthesia/analgesic administration; and other procedures as needed. The veterinary care unit also offers training for those who wish to perform these procedures themselves. For VRC studies conducted at other facilities, TRP establishes contractual agreements and coordination between investigators and these facilities. Within the in-house facility and contracted facilities, TRP ensures high-quality research in accordance with regulatory guidelines and compliance with good laboratory practices (GLP) and biosafety level requirements as essential.